Responding Together to Global Challenges

Project Summary
The Association of Environmental Engineering and Science Professors (AEESP Research and Education
Conference is a biannual gathering of researchers in environmental engineering, environmental science, health
sciences, and practitioners. The 2023 Conference, taking place in Boston, MA, will feature two workshops and
one technical session with an emphasis on the environmental health sciences as part of the larger theme of
“Responding Together to Global Challenges”.
The overall objective of the AEESP Research and Education Conference activities that will be supported
by NIEHS is to facilitate knowledge transfer and relationship building among environmental engineering,
environmental science, and environmental health professors and researchers. Specific objectives are: (1) to
educate environmental researchers on best practices for public health and community engagement within
environmental health research, (2) to make new connections between environmental engineering and science
professors and environmental and public health researchers for larger collaborative work in addressing
environmental health challenges, (3) to highlight recent advances in NIEHS-supported research related to
environmental quality, and (4) to broaden the participation of professors and trainees from universities and
demographic groups that are underrepresented in environmental engineering and environmental health sciences.
The activities for which NIEHS support is sought include two of the anticipated twenty conference
workshops and one of the seven planned technical sessions. Up to 400 attendees typically participate in
conference workshops, and about 100 participants are expected in the two environmental health science themed
events. The 2023 Conference will include these environmental health themed workshops as (1) Virus Monitoring:
Lessons Learned from a Global Pandemic, and (2) Forming Collaborations between Environmental Scientists and
Stakeholders in Public Health. A technical session, “Responding to Threats to Environmental Quality and Human
Health” will include several environmental health oral, poster, and keynote presentations.
The workshops and technical session will be organized by sub-committees comprised of representatives
from ten cooperating academic institutions. The travel grants supported by NIEHS will be awarded according to
an impact/priority score rubric. The communication, outreach, and invitation plans will strive to improve
representation of diverse researchers, students, and institutions. Conference activities and accommodations are
planned to be affordable to participants, supportive of family care, and accessible to persons with disabilities.

Public health relevance
Project Narrative The 2023 Association of Environmental Engineering and Science Professors Research and Education Conference, in Boston, will feature two workshops and one technical session that highlight recent advances in environmental health sciences. The overall objective of the AEESP Research and Education Conference activities that will be supported by NIEHS is to facilitate knowledge transfer and relationship building among environmental engineering, environmental science, and environmental health professors and researchers. NIEHS funds are requested to support travel grants for three invited speakers, and some graduate students, in need of financial assistance for attendance.